Molecular Imaging of Atherosclerosis in Peripheral Artery Disease

PROJECT SUMMARY
The long-term goal of this work is to develop a translatable imaging paradigm that enables comprehensive
assessment of multiple anatomical and physiological parameters in patients with peripheral artery disease
(PAD). Patients with lower extremity PAD are at increased risk of lifestyle limiting claudication, non-healing
wounds, amputation, and death, which is often attributed to deficits in limb perfusion and high levels of
vascular calcification above and below the knee. PAD patients with diabetes mellitus (DM) have accelerated
progression of peripheral vascular calcification, which reduces lower extremity muscle perfusion, limits options
for revascularization, reduces technical success rates of revascularization procedures, and increases risk for
amputation. Despite this knowledge, an ongoing challenge for the vascular medicine community is the lack of
standardized non-invasive imaging tests that quantify regional perfusion abnormalities as well as vessel-
specific calcific disease progression in PAD patients. Our team recently developed a novel dual-phase (i.e.,
combined dynamic and static) PET/CT imaging approach using 18F-NaF that quantifies both regional muscle
perfusion and vessel-specific active arterial microcalcification in the lower extremities during a single imaging
session using a single radioisotope dose injection. In the proposed projects, we will characterize the stages of
peripheral atherosclerosis targeted by 18F-NaF using an existing biobank of human arterial specimens
possessing varying degrees of calcium density and stiffness. We will then prospectively apply dual-phase 18F-
NaF PET/CT imaging to PAD patients with and without DM to quantify muscle-specific perfusion abnormalities
and vessel-specific calcium burden, and to predict vessel-specific calcium progression across a 1.5-year study
period. Following clinical evaluation of our approach, we will test the performance of deep learning image
segmentation methods for enabling efficient analysis of vessel-specific measures of active and established
arterial calcification as well as muscle-specific deficits in lower extremity perfusion from PET/CT images.
Completion of the proposed studies would lead to a comprehensive and scalable imaging approach that
quantifies multiple anatomical and functional parameters associated with PAD severity, calcium progression,
and clinical outcomes in PAD patients, which would improve the evaluation, monitoring, and risk assessment of
PAD patients who are at elevated risk of adverse limb and cardiovascular events.

Public health relevance
PROJECT NARRATIVE Lower extremity peripheral artery disease (PAD) is an atherosclerotic disease that is highly prevalent in patients with diabetes mellitus, who have accelerated progression of peripheral artery calcification above and below the knee that decreases limb blood flow and perfusion, reduces options for revascularization, and increases risk of limb loss and death. Our research team has developed a unique PET/CT imaging framework that provides quantitative evaluation of vessel-specific measures of active microcalcification and established calcium burden as well as muscle-specific measures of perfusion in PAD patients during a single imaging session using a single radionuclide injection. The overarching goal of the proposed projects is to further evaluate the clinical utility of this imaging approach for comprehensively assessing multiple anatomical and functional characteristics in PAD patients and ultimately providing the vascular medicine community with a non-invasive all-in-one tool that detects muscle-specific perfusion deficits, quantifies the early active stages of arterial calcification, and predicts risk of vessel-specific calcium progression and unfavorable clinical outcomes in PAD patients.